A druggable mito-nuclear feedback mechanism that preserves mitochondrial and synaptic function in old-age

ABSTRACT
Mounting evidence suggests mitochondrial decline is an early driver of Alzheimer’s disease and
related dementias (ADRD) but the underlying mechanisms remain unclear. Single-cell RNAseq
experiments revealed profound differences in the expression of nuclear DNA-encoded
mitochondrial genes between neuronal subtypes, suggesting a cell type-specific control of
mitochondrial gene expression depending on mitochondrial energy demands. Studying the role
of ATP synthase in aging and ADRD, we recently discovered a brain-specific mito-nuclear
feedback loop that controls mitochondrial gene expression in response to acetyl-CoA signals from
the mitochondria. This mito-nuclear feedback loop is activated by reducing ATP synthase activity,
activating AMPK, and subsequently blocking fatty acid synthesis by inhibiting acetyl-CoA
carboxylase 1 (ACC1). The block of fatty acid synthesis leads to an accumulation of acetyl-CoA,
H3K9 histone acetylation, and increased expression of nuclear-encoded mitochondrial proteins
by a mechanism that requires TAF1, the largest component of the transcriptional initiation complex
TFIID. Treatment with J147, a partial inhibitor of ATP synthase and an AD drug candidate,
increases acetyl-CoA and restores the expression of mitochondrial and synaptic genes, known
targets of TAF1. Conducting longitudinal electroencephalogram (EEG) recordings in PS19 mice,
an FTD mouse model expressing proteotoxic tau, we observed neuronal hyperexcitability and
non-convulsive seizure activity, specifically during slow-wave sleep (SWS). Activation of the mito-
nuclear feedback loop by treating the PS19 mice with J147 suppressed the neuronal
hyperexcitability and the observed pathological EEG features, revealing that they are likely the
consequence of early mitochondrial damage. Here, we hypothesize that age and pathological tau
destabilize the mito-nuclear feedback loop by lowering the mitochondrial acetyl-CoA synthesis
and export that is required for TAF1 to control synaptic and mitochondrial gene expression. Due
to their high mitochondrial energy demands, inhibitory neurons are preferentially susceptible to
mito-nuclear insults by tau, resulting in preferential damage to inhibitory neurons. Thus, we further
hypothesize that this preferential damage to the mitochondria of inhibitory neurons reduces
inhibitory tone and results in early hippocampal hyperexcitability and sleep loss, which can be
rescued by treatments that re-activate the mito-nuclear feedback loop.

Public health relevance
NARRATIVE In this application, we outline the existence of a brain-specific mio-nuclear feedback loop in which retrograde signaling from the mitochondria induces the synthesis of nuclear-encoded mitochondrial proteins in response to mitochondrial energy demands. Proteotoxc tau disrupts the mito-nuclear feedback loop and preferentially damages inhibitory neurons due to their high mitochondrial energy demands, resulting in neuronal hyper-excitability, sleep loss and, eventually, neurodegeneration.